Cell Preparation and Analysis Core

Cell Preparation and Analysis Core
ABSTRACT
Members of the faculty of Yale University have a longstanding interest in non-malignant hematological
research. This interest has further intensified in recent years, now encompassing multiple departments and a
variety of disciplines. The Cell Preparation and Analysis Core (Core A) was initially established within the
framework of Yale Cooperative Center of Excellence in Hematology (YCCEH) to address the needs and
challenges of non-malignant hematology research laboratories both at Yale and in other institutions, by providing
twelve services. Over the past four years, Core A has been successful in providing services and training, with
an average of ~50 Yale and ~10 non-Yale users annually. Core A also has effectively trained and/or serviced 97
junior researchers, and contributed to the publication of 30 papers. With the success of Core A in the past funding
cycle, we have also become increasingly aware of additional needs in non-malignant hematology research. We
thus propose to continue the success of existing service offerings and to incorporate new services and training
that answer to these additional demands from the hematology community. These 16 services and related training
are designed to address challenges facing hematology laboratories, including (1) the relative lack of access to
primary human cell populations and high commercial prices for the study of human hematopoiesis, (2) the wide
spread interest in emerging cell preparation and analysis techniques which are difficult to establish and optimize,
(3) the need to access primary patient samples, and (4) the necessity to train junior researchers to perfrom
essential hematology research techniques with rigor and high reproducibility. Core A will continue to be directed
by Dr. Diane Krause with the assistance of Associate Director Dr. Jun Lu. Additionally, Drs. Gary Kupfer and
Manoj Pillai will be Key Core Faculty participating in Core A services. Drs. Krause, Lu, Kupfer and Pillai have
extensive hematology research experience, which will be utilized to direct two research staff to provide effective
services to YCCEH members and those in other NIDDK CCEH consortium. Junior investigators are particularly
encouraged to use the Core services. Through centralization of key hematology techniques and establishment
of a common platform for training, Core A will help individual laboratories to considerably increase research
efficiency, reduce expense, and save valuable investigator time. The training aspect of the core will allow efficient
dissemination of relevant techniques and prevent redundancy of such efforts in member laboratories at Yale and
across the nation. By maintaining and providing exciting new emerging technologies, Core A fulfills the overall
goal of YCCEH so that innovative technical advances are shared and positively leveraged for the advancement
of non-malignant hematology research.